INTERFERON ALPHA 2B FOR THERAPY OF CHRONIC NON-A, NON-B, AND HEPATITIS C

The purpose of this study is to define the efficacy and safety of different doses of recombinant alfa interferon in patients with chronic non-A, non-B hepatitis and to assess the effect of dose escalation on patients who do not respond to conventional doses of the drug.